Synergistic Effects of Anxiety and Alcohol Use among Latinos and its Sociocultural Mechanisms

ABSTRACT
This is an application for a Mentored Patient-Oriented Research Career Development Award (K23) to support
the academic career development of the applicant. The candidate's long term goal is to become an independent
clinical investigator and national leader in the study of anxiety and substance use comorbidity among groups
prone to health disparities, with a particular emphasis on bidirectional and dynamic influences of anxiety and
alcohol abuse among Hispanics/Latinos. The applicant has conducted research focused on the development of
anxiety disorders across the lifespan, including their association with substance use outcomes. This application
builds on the applicant's expertise in the area of anxiety and follows a logical, but novel, progression from prior
research and training experiences to the development of a new area of expertise in alcohol-anxiety comorbidity
in a health disparities population. The application proposes training experiences that are necessary for the next
step in this research program, including advanced training in psychopharmacology of drugs of abuse; health
disparities; advanced statistical methods; and grant writing and science dissemination skills. The mentorship of
a select group of senior investigators will foster the candidate's development in a promising new area of research.
The goals of the proposed study are to examine (1) the pharmacological and expectancy mechanisms implicated
in the acute anxiety effects of alcohol, (2) the covariation between acute anxiety effects of alcohol and anxiety-
induced motivation to consume alcohol, and (3) sociocultural (perceived racial discrimination) influences in these
outcomes in a sample of moderate-to-heavy drinking adult Hispanics/Latinos ages 21-65. This approach is novel
in that it aims to examine several complex alcohol-anxiety associations among Hispanics/Latinos in one
overarching model, which has yet to be attempted in a human experimental paradigm. This proposal is
conceptualized as a prototypical example of cross-disciplinary translational research that can explicate
mechanisms from a multi-method framework to enhance our understanding of complex anxiety-alcohol relations,
and serve as a catalyst for future work in this emerging domain among a group prone to health disparities. The
proposed study will use rigorous methods of assessment to address three primary aims: 1) to test the
pharmacological and expectancy effects of acute alcohol stress dampening, 2) to test anxiety a proximal
antecedent of urge to drink and ad lib alcohol consumption, and 3) to test associations between perceived racial
discrimination and Aim 1 and 2 outcomes in a large sample of Hispanics/Latinos. The training and research
outlined in this proposal will equip the candidate with a unique set of necessary skills to advance knowledge in
this important yet understudied area. Over the long-term, data from this study will enhance understanding of the
mechanisms involved in the alcohol-anxiety connection among Hispanics/Latinos and will directly inform and
strategically guide the development of novel treatments for health disparities populations.

Public health relevance
PROJECT NARRATIVE The societal impact of heavy alcohol consumption and anxiety disorders among Hispanics/Latinos is substantial and warrants considerable research investment into their co-occurrence. By examining pharmacological and expectancy effects of acute alcohol stress dampening, anxiety as a proximal antecedent of urge to drink and ad lib alcohol consumption, and sociocultural influences in these outcomes in a sample of moderate-to-heavy drinking Hispanics/Latinos, results from this study can directly inform and strategically guide the development of novel treatments for health disparities populations.